OPEN LABEL TRIAL OF PREDNISONE IN FSHD

To determine the efficacy of prednisone in the treatment of facioscapulohumeral muscular dystrophy (FSHD). an open label trail is planned in order to obtain preliminary data to justify a double-blind controlled trial. This protocol has now been terminated.